Structural and Biochemical Studies of HIV and MMTV Retroviral Integration onto Nucleosome-bound Target DNA

Summary/Abstract:
cells
The integration of viral DNA (vDNA) into host chromatin establishes an infection in target
and is a hallmark of the replication cycle of all retroviruses, including the Human
Immunodeficiency Virus (HIV). Integration is catalyzed by the intasome, a complex consisting of
multimers of viral integrase proteins and short vDNA oligonucleotides. Most prior work used free
target DNA to probe retroviral integration, largely due to experimental simplicity. However,
eukaryotic host target DNA is chromatinized, with nucleosomes forming the core structural
building blocks of the genome. Accordingly, our understanding of intasome-mediated integration
into chromatin remains incomplete. This proposal will employ novel nucleosome reconstitution
and sequencing strategies, biochemical binding and activity assays, and high-resolution
cryogenic electron microscopy (cryo-EM) to mechanistically interrogate how and where
retroviruses integrate vDNA into chromatin. Three Scientific Aims will be developed using HIV
and, as a simpler model system, the Mouse Mammary Tumor Virus (MMTV). In Aim 1, a novel
assay will be utilized to interrogate intasome binding preferences on nucleosome assemblies. In
Aim 2, the preferred patterns of intasome-mediated integration into and around nucleosomes will
be defined. In Aim 3, structures of intasomes bound to nucleosome assemblies will be solved
using cryo-EM to dissect the mechanistic basis of integration into chromatin. Preliminary results
recently obtained revealed that intasomes selectively integrate into nucleosomal super helical
locations that were not previously reported, highlighting both the novelty and significance of the
proposed work. Collectively, these studies will advance mechanistic studies underlying the key
integration step catalyzed by retroviruses, and the results will have important implications for
understanding how these viruses cause diseases that affect millions of people around the world.
During the training period, the PI will benefit from the collaborative and scientifically
diverse environment present within the Biological Sciences PhD program at UCSD/Salk Institute.
With the aid of his two sponsors, the PI will become proficient in numerous technical skills,
including but not limited to protein expression and purifications, biochemical activity assays, next
generation sequencing, and cryo-EM data collection, processing, and atomic model refinement.
Moreover, the PI will enhance his scientific soft skills by presenting his research at conferences,
attending grant and manuscript writing workshops, mentoring undergraduate students, and
teaching courses. Collectively, the NRSA Predoctoral Fellowship will prepare the PI to become
an independent researcher for his next stage of academic training as a postdoctoral associate.

Public health relevance
Project Narrative: Catalytic integration of viral DNA into the target host genome is a hallmark of the infection cycle of all retroviruses, including the Human Immunodeficiency Virus (HIV). Using in vitro biochemistry and structural biology, my research aims to define how and where retroviral intasomes, which are the molecular machines that mediate integration, catalyze viral DNA integration into chromatin assemblies. The outcome of the work will provide novel insights into patterns and preferences of viral DNA integration into and around nucleosomes and dissect the structural bases of integration into chromatin.